Multiplexed proteomics-based kinase assay development

Project Summary
This supplement project is to support Justin Gonzalez in a postbaccalaureate research and
career development training experience alongside the goals of R01GM146386. Justin will
engage with students receiving focused career development training through other scaffolded
programming at the University of Minnesota, and gain research skills towards application to
graduate programs or other long term career goals in biomedical research. He will also engage
with his mentor, Dr. Parker, in weekly research and career development discussions to help him
in his exploration of research areas and graduate program opportunities. He will work on a
research project to test novel substrates for the TAM family of kinases that were designed using
AI-based structural approaches, and characterize the kinetic parameters for substrate-kinase
pairs.

Public health relevance
Project Narrative From parent project: Kinase inhibitor drugs have changed the face of therapeutics and are projected to remain a major focus of drug development, however, their long-term efficacy is variable because of biological complexity and resistance. We are developing assay strategies that can be used to study kinase signaling biology, and screen new drugs and drug combinations in a way that better mimics biological complexity. These could someday also be used as companion diagnostics for the drugs they help discover, to monitor the effectiveness of treatment, finding resistance earlier so patients can try alternatives that could improve their treatment outcomes. References Jumper, J., R. Evans, A. Pritzel, T. Green, M. Figurnov, O. Ronneberger, K. Tunyasuvunakool, R. Bates, A. Zidek, A. Potapenko, A. Bridgland, C. Meyer, S. A. A. Kohl, A. J. Ballard, A. Cowie, B. Romera-Paredes, S. Nikolov, R. Jain, J. Adler, T. Back, S. Petersen, D. Reiman, E. Clancy, M. Zielinski, M. Steinegger, M. Pacholska, T. Berghammer, S. Bodenstein, D. Silver, O. Vinyals, A. W. Senior, K. Kavukcuoglu, P. Kohli, and D. Hassabis. 2021. 'Highly accurate protein structure prediction with AlphaFold', Nature, 596: 583-89. Tunyasuvunakool, K., J. Adler, Z. Wu, T. Green, M. Zielinski, A. Zidek, A. Bridgland, A. Cowie, C. Meyer, A. Laydon, S. Velankar, G. J. Kleywegt, A. Bateman, R. Evans, A. Pritzel, M. Figurnov, O. Ronneberger, R. Bates, S. A. A. Kohl, A. Potapenko, A. J. Ballard, B. Romera-Paredes, S. Nikolov, R. Jain, E. Clancy, D. Reiman, S. Petersen, A. W. Senior, K. Kavukcuoglu, E. Birney, P. Kohli, J. Jumper, and D. Hassabis. 2021. 'Highly accurate protein structure prediction for the human proteome', Nature, 596: 590-96. Widstrom, N. E., G. V. Andrianov, J. L. Heier, C. Heier, J. Karanicolas, and L. L. Parker. 2023. 'Novel Substrate Prediction for the TAM Family of RTKs Using Phosphoproteomics and Structure-Based Modeling', ACS Chem Biol. Accession Number: 38159292 DOI: 10.1021/acschembio.3c00549